Enhancing prognosis communication for older adults in skilled nursing facilities

PROJECT SUMMARY/ABSTRACT
This is an application for a Beeson K76 award for Dr. James Deardorff, a geriatrician and Assistant
Professor at the University of California, San Francisco. Dr. Deardorff's career goal is to become an
independent investigator focused on trialing methods to optimize prognosis communication for older adults
receiving post-acute care at a skilled nursing facility (SNF). Nearly 20% of hospitalized older adults are
discharged to a SNF, representing 1.8 million SNF stays annually. While SNF admissions are often focused on
short-term rehabilitation with the goal of returning home, they represent a particularly vulnerable time for older
adults: ~20% are re-admitted to the hospital and ~15% transition to long-term nursing home care. Many
patients receive overly optimistic information about their health trajectory and feel blindsided when their goals
are not met. SNF patients could benefit from a communication tool that provides accurate and personalized
prognostic information about the likelihood of various outcomes, yet that tool does not yet exist.
Dr. Deardorff has a strong background in developing prognostic calculators and has created a prognostic
model for older adults at SNFs using logistic regression through an R03 GEMSSTAR, which predicts the
likelihood of hospital re-admission, nursing home transition for long-term care, and 6-month mortality. However,
this model could be improved upon through novel machine-learning methods, and simply developing prediction
models is not enough; they must be used to impact change. This K76 proposal addresses a critical gap in SNF
care by developing and implementing a prognosis communication tool containing personalized prognostic
information. Mentored by an extraordinary team led by Dr. Sei Lee, Dr. Deardorff will: 1) develop and compare
novel multi-outcome machine learning-based models to traditional logistic regression to ensure highly accurate
risk estimates (Aim 1); 2) assess prognosis communication needs through semi-structured interviews with key
SNF informants and develop and refine a SNF prognosis communication tool containing prognostic estimates
from the best performing model in Aim 1, anticipatory guidance for SNF care, and questions to elicit patients'
values and preferences (Aim 2); and 3) pilot the prognosis communication tool to evaluate its feasibility,
acceptability, and preliminary impact on patient-centered outcomes (Aim 3). These Aims correspond with
career development activities focused on 1) advanced machine learning methods to develop high-performing
prognostic models, 2) qualitative research skills to understand facilitators and barriers to communicating
prognostic estimates, 3) development and implementation of communication tools in SNFs, and 4) leadership
skills. Results will inform an R01 proposal to evaluate the effectiveness of the prognosis communication tool on
patient-centered outcomes in a randomized clinical trial within SNFs. Dr. Deardorff will receive the necessary
training and experience in machine learning, qualitative research, implementation science, and pragmatic trial
design to launch his career as a leading investigator in post-acute care for older adults at SNFs.

Public health relevance
PROJECT NARRATIVE Older adults admitted to a skilled nursing facility (SNF) for post-acute rehabilitation after a hospitalization represent a vulnerable population at high risk for adverse events, and they would benefit from a communication tool that provides personalized prognostic information to help guide future planning and shared decision-making. This K76 Beeson proposal will (1) develop and compare novel machine learning-based prognostic models to traditional regression for predicting multiple outcomes while at a SNF (hospital readmission, transition to a nursing home for long-term care, and 6-month mortality), (2) assess prognosis communication needs and develop and refine a SNF prognosis communication tool which contains personalized prognostic risk estimates, anticipatory guidance for SNF care, and questions to elicit values and preferences, and (3) pilot the prognosis communication tool in a SNF to evaluate its feasibility, acceptability, and preliminary impact on patient-centered outcomes. The prognosis communication tool developed and pilot- tested through this proposal will help improve clinical care for patients at a SNF by increasing prognostic awareness, aligning expectations through enhanced communication, and facilitating shared decision-making discussions.